RNA regulation in medium spiny neurons of the striatum in Parkinson's disease

PROJECT SUMMARY/ABSTRACT
Research: Parkinson's disease is characterized by degeneration of dopaminergic neurons in the substantia
nigra, leading to reduced dopaminergic input to the striatum and subsequent motor and cognitive deficits. While
the loss of presynaptic dopamine input initiates striatal dysfunction, mere replacement of dopamine is insufficient
to effectively treat the disease over time. This gap in knowledge has spurred interest in understanding the
molecular dysfunction within the postsynaptic neurons of the striatum. D1 and D2 neurons, named for their
predominant expression of dopamine receptors D1 and D2, are the principal postsynaptic neurons of the
striatum. They exhibit distinct downstream signaling mechanisms in opposing pathways that together influence
striatal function. The overall objective of this project is to identify the molecular mechanisms underlying striatal
dysfunction in Parkinson’s disease by investigating aberrant glutamate and dopamine receptor signaling
separately in D1 and D2 postsynaptic neurons. This study focuses on the cell-type specific role of the neuronal
RNA-binding protein ELAVL3, whose levels are altered in Parkinson’s disease. ELAVL3 is a known modulator
of alternative splicing of mRNAs encoding proteins critical for glutamate and dopamine receptor signaling in the
mouse striatum. The central hypothesis is that altered RNA-binding function of ELAVL3 leads to aberrant splicing
in D1 and D2 neurons, ultimately disrupting striatal function in Parkinson’s disease. The applicant will test this
hypothesis by leveraging technical breakthroughs in her mentors’ laboratories that enable the isolation of D1 and
D2 neurons from postmortem brains to study RNA regulatory mechanisms within specific cell types. The project
has two specific aims: 1) To identify the role of alternative splicing in aberrant glutamate and dopamine receptor
signaling in Parkinson’s disease 2) To determine the role of ELAVL3 on alternative splicing and downstream
signaling in D1 and D2 neurons in Parkinson’s disease. This research is expected to shed light on the molecular
mechanisms involved in striatal dysfunction in Parkinson’s disease, potentially leading to the development of
novel therapeutic approaches. Candidate: The applicant Dr. Krithi Irmady is a movement-disorders neurologist
and Instructor at the Rockefeller University, who aims to become an independent, tenure-track physician-
scientist investigating RNA biology in Parkinson’s disease. Dr. Irmady has outlined a five-year period of mentored
training where she will develop skills in fluorescence activated nuclear sorting, cell-type specific profiling of RNA
binding protein targets, and experimental manipulation of splicing in neuronal culture systems to study RNA
dysregulation in Parkinson’s disease. Environment: The proposed research will be done in Rockefeller
University, one of the world’s leading biomedical research universities. The University exposes trainees to an
exceptionally robust academic research environment with a strong commitment and track record of successfully
supporting junior faculty who are seeking careers as independent investigators.

Public health relevance
PROJECT NARRATIVE: The proposed research is relevant to public health because it focuses on uncovering new insights into the biology of Parkinson’s disease, a debilitating progressive neurological disease and movement disorder, for which there is currently no cure. This study will investigate how gene regulation in specific brain cells controlling movement may be affected by Parkinson’s disease. Ultimately, this work will further our understanding of mechanisms underlying the disease and identify new opportunities for treatment.